Neuroimaging of Instrumental Learning Networks in Adolescent Cannabis Use Treatment

PROJECT SUMMARY/ABSTRACT
The candidate’s long-term goal is to shift his research focus from examining neural correlates of
individual differences in adolescent substance use disorders toward neurobiological predictors of individual
treatment outcomes. Through the research and training in this K23 proposal, the PI will acquire training in
multivariate statistics/machine learning methods and clinical research necessary to make this transition.
Adolescent cannabis use is a serious public health problem. 6% of high school seniors report daily
cannabis use and 3% of adolescents meet criteria for CUD. Although cannabis is increasingly becoming
legal at the state level, cannabis is associated with increased risk of psychiatric disorders, cardiovascular
disease, and respiratory disease. However, CUD treatment responses are inconsistent. Contingency
management (CM) is a critical component of CUD treatment and relies on instrumental learning to reduce
cannabis use by rewarding abstinence from cannabis use. However, little work has investigated whether
integrity of brain networks underlying instrumental learning predict CUD symptom severity, and no work has
investigated whether performance on an instrumental learning task predicts cannabis use outcomes
following CM. Therefore, the proposed K23 project will address the candidate’s training goals while gathering
preliminary and feasibility data supporting the next step in his research. The proposed research study aims
to: (1) identify associations between CUD symptomatology and neural activity during instrumental learning
and (2) examine whether neural activity during instrumental learning is associated with reduced cannabis
use frequency during CM treatment.
The PI proposes to accomplish these aims by collecting fMRI and report-based data from a sample of 76
youth ages 14-18 who use cannabis at least once per week. All youths will complete a screening visit, an
fMRI scanning visit, 10 virtual CM sessions, and a follow-up visit. We anticipate that findings will show the
extent to which disruptions in neural systems underlying instrumental learning are associated with CUD
symptoms and the extent to which neural activity instrumental learning predicts contingency CM outcomes.
This K23 application proposes training and research that is directly in line with NIDA objectives and
represents a logical progression from the PI’s prior experience to address career development goals in three
areas: (1) use of multivariate and machine learning techniques in analyzing neuroimaging data; (2) clinical
research. The experience and findings from the proposed K23 will position the PI to pursue NIH funding and
build this line of research through a large mechanistic clinical trial of CM treatment on adolescent cannabis
use and the role of neuroimaging data in individualized treatment outcomes.

Public health relevance
PROJECT NARRATIVE Adolescent cannabis use disorder (CUD) has a high economic, social, and health cost that impacts many Americans. This project will use cutting-edge machine learning techniques to investigate the role of neural instrumental learning systems in cannabis using adolescents and whether integrity of instrumental learning systems predicts success during contingency management treatment. The immediate goal of this project is to identify reproducible markers of CUD symptom levels and predictors of contingency management success, with the long-term goal of conducting mechanistic clinical trials aimed at testing neurobiological predictors of individual differences in treatment success.